Administrative Core

PROJECT SUMMARY/ABSTRACT
The primary function of the PDTC Administrative Core will be to coordinate, align, and connect the elements of
the Center. As such, the Administrative Core will coordinate scientific and administrative functions, meetings,
communications, operations management, project and core interactions, and financial management. The
Administrative Core fulfills essential oversight and management functions, and oversees efficient utilization of
resources. The core will ensure timely achievement of specific milestones for each Project and Core and will
support, in particular, the successful communication and coordination with the PDXNet, the PDX Data Commons
and Coordinating Center (PDCCC), and the NCI.